SCGE Disease Models Studies Supplement: Repair of a CFTR Nonsense Mutation Using Adenine Base Editing

Abstract: CFTR nonsense mutations cause a severe cystic fibrosis (CF) phenotype, unresponsive to current
small molecule therapies. Correcting CFTR nonsense mutations in 5–15% of airway epithelia by installing a
single nucleotide A>G change using an adenine base editor (ABE) should restore CFTR mediated Cl−
secretion to healthy levels. We have optimized amphiphilic shuttle peptides for delivery of CRISPR associated
nuclease ribonucleoproteins (RNP) to mouse airways and ABE RNP to rhesus monkeys, achieving therapeutic
editing levels ≥5%. We propose to deliver ABE RNP to the airways of mice bearing the human CFTR R553X
nonsense mutation. In this model, mouse CFTR exon 12 was entirely replaced with human exon 12 sequence.
While substitution for wildtype human sequence has no negative consequences on mice, introduction of
human R553X mutation in the substituted exon 12 causes a CF phenotype (intestinal obstruction at weaning,
loss of CFTR function in airway epithelia and intestinal organoids). This is one of the only animal models of a
CFTR nonsense mutation with a disease phenotype. We previously demonstrated ex vivo that ABE RNP
delivered using shuttle peptides can efficiently revert the R553X mutation in human airway cells. Our
overarching goals are 1) to optimize ABE8e RNP editing, 2) to repair the R553X mutation in the airway
epithelia of mice with sufficient efficiency to restore CFTR function, and 3) to investigate the safety, toxicity,
and off-target effects of the editing approach while advancing towards clinical trials with this method.

Public health relevance
Narrative (lay summary): The proposed research is relevant to the public health because genetic and acquired diseases affecting the airways pose major disease and economic burdens. By advancing the delivery and efficacy of gene editing tools, it may be possible to therapeutically modify the cells lining the airways. This strategy may improve treatment options for both monogenetic and acquired lung diseases, and may have applications for other somatic cell therapies.